Targeting glioblastoma with CM93, a novel EGFR inhibitor with exceptional brain penetration

PROJECT SUMMARY
The epidermal growth factor receptor (EGFR) gene is mutated and/or amplified in majority of
primary glioblastoma (GBM). While EGFR-mutant GBM cancer cells are dependent on EGFR
signaling for survival, numerous small molecule EGFR tyrosine kinase inhibitors (TKIs) have failed
to show efficacy in this disease. There are two main reasons for these failures: i) Many of these
EGFR-TKIs fail to cross the blood-brain barrier (BBB); ii) These EGFR-TKIs were developed to
specifically target mutant EGFRs with mutations in the kinase domain found in non-small cell lung
cancer (NSCLC), but they have poor activity (low binding affinity) against GBM EGFR variants
with a wild-type tyrosine kinase domain. CM93 has been developed at Crimson Biopharm as a
novel therapeutic agent to specifically tackle these challenges in treating GBM. CM93 has distinct
features that set it apart from all other EGFR-TKIs, including osimertinib. CM93 is highly enriched
in the brain, with an exceedingly low blood concentration (>2,000% brain penetration). This
extraordinary property of CM93, in conjunction with its high potency against EGFR with wild-type
tyrosine kinase domain, offers a powerful and unique opportunity for CM93 to effectively inhibit
GBM with EGFR variants without significant systemic toxicity. Notably, CM93 has received IND
approval for the first-in-human phase 1 clinical trial in GBM patients and is currently part of
NIH/NCI’s “Glioblastoma Therapeutics Network (GTN)” to conduct phase 1 and surgical window
studies led by Dr. Patrick Wen, Director of Neuro-Oncology at Dana-Farber Cancer Institute
(DFCI). The overall objective of this STTR application is to evaluate the combination of CM93 with
abemaciclib (an approved CDK4/6 inhibitor with notable CNS activity as proposed in Aim1 and
biomarker analyses in Aim 2 in patient-derived GBM models to provide important pre-clinical proof
of concept to better support CM93’s first-in-human phase 1 and window-of-opportunity surgical
studies.

Public health relevance
PROJECT NARRATIVE Primary glioblastomas (GBMs) are fast-growing and aggressive brain tumors in adults that are uniformly fatal with limited therapeutic options. To meet this significant unmet need, Crimson Biopharm is developing CM93, a novel EGFR small molecule drug, that has an exceptional brain enrichment with an exceedingly low blood concentration, to specifically treat majority of primary GBM with EGFR alterations. In this STTR application, we propose to perform translational studies to provide critical preclinical proof of concept needed to better support the first-in-human clinical trial of CM93 in patients with GBM to transform the treatment landscape for this formidable disease.